Racial Disparities in the Mechanisms of Prostate Cancer Metastasis

Project Summary/Abstract
Prostate cancer (PCa) is responsible for one of the greatest racial health disparities, with African-American
(AA) men experiencing a death rate 2.4 times higher than that for EA men, which accounts for nearly 40% of
the total overall cancer mortality disparity between AA and EA men. PCa mortality is largely due to metastases,
and thus it is critical to understand the racial disparities in the mechanisms of metastasis in AA PCa. Our
preliminary studies have shown that genes related to oxidative phosphorylation (OXPHOS) are enriched in
PCa tumors from AA men relative to EA men, as well as between normal tissue, primary tumors, and LNM.
FGFR3 is a fibroblast growth factor tyrosine kinase receptor that binds to fibroblast growth factor ligands and
activates OXPHOS, PI3K/AKT, STAT, RAS/MAPK, and ERK signaling pathways. We have also discovered
splice site mutations in FGFR3 that are present in both primary tumor foci and LNM and have shown that
FGFR3 mutations are more frequent in metastases than primary tumors examining data from over 6500
samples. We have also determined that FGFR3 expression is significantly correlated with % African ancestry
in TCGA patients, and we have identified three SNPs in the FGFR3 enhancer with >40% allele frequency
differences in AA populations. Moreover, FGFR3 expression was significantly higher in our datasets of
prostate tumors from AA men than from EA men. We hypothesize that the OXPHOS pathway and FGFR3
signaling play important roles in metastasis for AA men. We plan to test this hypothesis via the following
Specific Aims: Aim 1. To analyze differential pathway activity in independent diverse patient cohorts. We
hypothesize that FGFR3 and OXPHOS genes will be associated with African ancestry and metastasis. We will
confirm and validate our preliminary findings examining prostatectomies, circulating tumor cell clusters, and
metastatic biopsies. Aim 2. To analyze the impact of perturbation of FGFR3 signaling on metastasis using in
vitro and in vivo models of AA prostate cancer. We hypothesize that increased FGFR3 expression and/or
FGFR3 mutations may activate OXPHOS activity, promoting metastasis. We will investigate the mechanisms
of disparities in regulation of FGFR3 expression and the impact of these novel mutations. Aim 3. To determine
the effect of perturbation of OXPHOS on the metastatic potential of AA prostate cancer cell lines in vitro and in
vivo. We hypothesize that OXPHOS activity promotes metastasis in AA PCa. We will manipulate OXPHOS
activity to understand how it impacts metastasis in models of AA PCa. Completion of these studies will
provide new insights into PCa metastasis in AA men, demonstrate the potential clinical utility of FGFR3 and/or
OXPHOS inhibitors, and could ultimately help reduce cancer health disparities.

Public health relevance
Project Narrative This project will study the roles of the tyrosine kinase receptor FGFR3 and the oxidative phosphorylation pathway in prostate cancer health disparities. Differences between patients of African and European descent will be examined and mechanisms of how FGFR3 and oxidative phosphorylation contribute to metastases in African-American men will be studied.